CHO Metabolism Disorder, Acanthosis Nigricans NIDDM/ Risk

Severity of CHO metabolism deragements correlates with severity of acanthosis nigricans in children and adolsecents at risk of developing Type 2 diabetes mellitus.